Core C - Computational and Quantitative Imaging Core

ABSTRACT: Computational and Quantitative Imaging (Core C)
Advances in imaging have improved our understanding of tumor heterogeneity, normal tissue variability, and
early detection of tumor response and normal tissue toxicity. The rich information content of these advanced
imaging methods, combined with the growing capacity to collect multiple types of images from various sources
and of various dimensions (2D, 3D, 4D) and time points during therapy opens an exciting prospect for image-
based guidance and assessment of clinical interventions. A major obstacle to full exploitation of this paradigm is
the natural deformations (i.e., positional differences in soft tissue, deformation during swallowing and breathing,
and morphologic soft tissue change) in anatomy between imaging events or between imaging and intervention
events. This obstacle must be removed to harness and leverage the information presented in the data. The
Computational and Quantitative Imaging Core will further optimize and deploy anatomical models incorporating
2D information into 3D models will quantify the complex physiologic changes of the patient over time. Further,
we will enable novel deep learning methods to harness this information into toxicity prediction models which will
allow us to reduce the severity and frequency of toxicity events for future patients. The innovative, multi-
disciplinary development and deployment proposed here will advance these anatomical models to facilitate high
precision, localized, image guided cancer therapy in the head and neck. These tools will be focused on the
following specific aims:
Aim 1: Automated Segmentation and Image Processing Algorithms. Leveraging our ongoing, successful
work in tumor and normal tissue segmentation on CT and MR, we will expand to include comprehensive
segmentation tools for all organs, tumors, and structures of interest in the head and neck on CT, MR, fluoroscopy,
and optical imaging in support of correlative pathology.
Aim 2: 2D/3D/4D Biomechanical Model-based Deformable Image Registration. This suite of tools will include
2D (fluoroscopy, cine, and histopathology imaging), 3D (CT, MR, and optical images obtained during correlative
pathology), and 4D (multi-time point and dynamic imaging) image registration across all imaging modalities as
well as the incorporation of dose throughout the registration process.
Aim 3: Deep Learning Prediction Models. Interpretable deep learning and traditional machine learning
algorithms are critical to support the toxicity and outcomes prediction models planned in all projects.

Public health relevance
NARRATIVE: Computational and Quantitative Imaging (Core C) Nearly all patients treated with surgery and radiotherapy report some degree of therapy-related side effects due to normal tissue injury, such as xerostomia, osteoradionecrosis and difficulty swallowing, with the majority experiencing symptoms that significantly impact quality of life. Reducing these toxicity rates requires precision in treatment, understanding what treatment is delivered to patients, spatially and temporally linking quantitative measurements of toxicity with the treatment delivered, and finally, harnessing this wealth of information to benefit future patients. The innovative research proposed will further develop and deploy automated segmentation and image processing algorithms for widespread use across diagnostic, therapeutic, and response assessment timepoints, advance anatomical models to facilitate high precision, localized, image guided cancer therapy in the head and neck through the development of anatomical models to incorporate 2D information into 3D/4D models, quantify the complex volumetric changes of the patient over the treatment course, and harness deep learning techniques to predict the toxicity risks for future patients enabling the optimization of therapeutic interventions.